Identifying clinically relevant neural circuit mechanisms of cognitive control training for PTSD

Posttraumatic stress disorder (PTSD) is prevalent, debilitating, and associated with significant levels of
functional impairment in Veterans seeking care at the VA. Despite evidence that current treatments for PTSD
are effective, a substantial portion of individuals maintain elevated PTSD symptoms after first line treatments.
Mechanistic insight and tools that improve the neurocognitive and affective mechanisms that underlie
successful clinical outcomes from evidence-based psychotherapies, like prolonged exposure, are highly
needed. One of the most prominent mechanisms associated with therapeutic symptom reduction in PTSD is
fear extinction. Indeed, extinction learning is a key theoretical treatment target in exposure-based therapies for
PTSD. Fear extinction learning is not only an emotional process, but relies on an individual's cognitive control
abilities, including working memory (WM). Under a WM framework, high WM ability offers the ability of an
individual to adjudicate the competition between threat and extinction memory expression as they repeatedly
encounter feared cues that are no longer threatening. Consistent with this hypothesis, previous investigations
and preliminary data from our group shows replicable findings that variation in WM ability is associated with
laboratory measures of fear extinction learning including threat expectancy ratings, psychophysiological, and
dorsal anterior cingulate cortex (dACC) activity. Our team has also shown that psychophysiological and neural
measures of fear extinction is a construct malleable to treatment. Moreover, our preliminary data show that
elevated PTSD symptoms are associated with increased dACC and decreased posterior hippocampal activity
during fear extinction and that WM ability is negatively associated with PTSD symptom severity. We also show
data in civilian populations that a brief WM training (WMT) designed to boost WM is feasible and is effective
in enhancing behavioral and neural markers of WM ability, and is feasible in a sample of Veterans with PTSD.
Critically, we provide evidence in two independent datasets that 1) WMT is associated with an EEG measure of
fear extinction and 2) a decrease in anxiety during exposure trials. These preliminary findings raise the
intriguing possibility for the mechanistic link between WM and extinction, and that enhancing WM ability
through WMT may also improve fear extinction learning success in Veterans with PTSD.
The current proposal aims to answer these questions in two ways. First, in a between-group design,
Veterans diagnosed with PTSD will complete 8-sessions of working memory training (WMT) or sham-training
(ST) over a four-week period. At pre- and post-training, Veterans will complete a standard fear acquisition &
extinction learning task in addition to tasks assaying WM capacity and cognitive control. We will identify
whether WMT modulates behavior, psychophysiological, and neural changes in extinction learning. Second,
independent of WMT, we will further test the conceptual link between WM and extinction in Veterans with
PTSD by testing whether neural circuits associated with high WM capacity and extinction learning are linked.
To this end, we will leverage novel computational modeling of extinction learning to track dynamic memory
updating to test the conceptual mechanistic link between WM and extinction. To ascertain the relevance to
PTSD symptoms, we will compute an exploratory multi-task canonical correlation analysis to identify the
multivariate patterns linking WM, fear extinction to specific PTSD symptom sub-clusters. The project is
expected to determine if a cognitive control training program targeting WM capacity shows the potential to
enhance behavioral and neural markers of fear extinction, mechanisms that are clearly integral to current
PTSD treatments. These aims support the VA mission of testing and evaluating innovative treatment targets
for PTSD. Results will provide a mechanistic foundation for future clinical trials that test whether adding WMT
prior to or in conjunction with exposure-based psychotherapies will improve clinical outcomes and further
clarify existing mechanistic and neurobiological models of PTSD and its treatment for Veterans.

Public health relevance
Dysregulation in fear extinction is a hallmark feature of PTSD and is a critical treatment target in exposure therapy. Yet, a significant number of Veterans maintain elevated symptoms after treatment, indicating a need to identify the mechanistic underpinnings of extinction and develop tools to enhance extinction learning. To this end, the proposed study will test whether a working memory training (WMT) program improves fear extinction learning and its underlying neural circuitry. We will further validate the relationship between working memory and fear extinction using novel computational and multivariate analyses that link to specific PTSD symptoms. If WMT can enhance fear extinction learning, then WMT may be a powerful adjunctive treatment that can enhance exposure therapy outcomes or be leveraged as a stand-alone treatment. This project supports the CSR&D’s mission of developing viable targets of treatment for PTSD.